Comprehensive Toileting Programming: Enuresis Treatment to a Randomized Clinical Trial of a Caregiver-Mediated Multidisciplinary Intervention for Encopresis

Project Summary/Abstract
Encopresis (fecal incontinence) and enuresis (urine incontinence) are prevalent in autistic youth and can
have a negative impact on quality of life (Kroeger et al., 2009). Evidence supports behavioral interventions for
enuresis. However, encopresis persists despite successful intervention for enuresis for a subset of autistic youth
(Lomas Mevers et al., 2018). Unfortunately, the timeline for achieving fecal continence after successfully
completing enuresis treatment is unclear and there is no available evidence on which individuals are likely to
acquire fecal continence independently after urine treatment versus those who will continue to experience
encopresis and require additional intervention. For those individuals who do require specific intervention for
encopresis, our group has developed and tested the Multidisciplinary Intervention for Encopresis (MIE), which
integrates physiological mechanisms (resolution of constipation before treatment and use of suppositories in
treatment, if needed) and behavioral mechanisms (reinforcement of continent bowel movements). Randomized
clinical trials (RCTs) of MIE have demonstrated feasibility, acceptability, and efficacy for improving encopresis
with minimal side-effects when implemented in a specialty clinic with trained therapists. Unfortunately, this
service model poses access barriers - especially for children in rural areas.
This study aims to address these research gaps by assessing the progression from urine treatment to BM
continence and evaluating a novel caregiver-mediated service model of MIE (CM-MIE) to improve accessibility.
We will recruit two groups of participants: (a) autistic youth with both enuresis and encopresis and (b) autistic
youth with encopresis alone. Those with both enuresis and encopresis (N=70) will enter a pre-randomization
phase consisting of enuresis treatment and a monitoring period to assess fecal continence. This pre-
randomization phase will allow determination of what proportion of youthbecome continent for bowel movements
following enuresis treatment without additional intervention and how long after enuresis treatment this fecal
continence emerges (Aim 1). We will also analyze participant characteristics that might relate to acquiring fecal
continence in this phase (Aim 2). Those who continue to experience fecal incontinence in the pre-randomization
period will join the participants who entered the study with encopresis alone and enter the randomized phase of
the study (N=60; 30 per group) comparing CM-MIE to a parent education (PE) program focused on encopresis.
Outcomes of the RCT (Aim 3) are the Clinical Global Impression – Improvement Scale rated by a treatment-
blind Independent Evaluator and caregiver stress measured by the Caregiver Strain Questionnaire. An
exploratory aim will evaluate participant characteristics that impact response to encopresis treatment. This
innovative study will be the first to evaluate the progression from enuresis treatment to fecal continence in well-
characterized autistic youth and the first to evaluate a caregiver-mediated intervention for encopresis.

Public health relevance
Project Narrative Encopresis (fecal/bowel incontinence) is a common, but understudied, concern for autistic youth with some autistic youth experiencing persistent encopresis afteracquiring urine continence. Currently, little is known about the progression from urine to fecal continence and empirically supported interventions specifically targeting encopresis are limited to highly specialized clinic settings, which may limit accessibility. The current study aims to address these research gaps by (a) monitoring fecal continence after autistic youth complete enuresis treatment and (b) for individuals who continue to experience encopresis after acquiring urine continence, evaluate a caregiver-mediated version of a Multidisciplinary Intervention for Encopresis (CM-MIE) delivered via telehealth to determine efficacy in a randomized clinical trial.